Bioinformatics and Genomics Core

III. Bioinformatics and Genomics Core Abstract
The overall goal of the NH-INBRE Bioinformatics and Genomics Core (BGC) is to overcome the gap in
bioinformatics expertise by direct support of ongoing and new research projects and fostering integration of
bioinformatics into the undergraduate curriculum. The need for support for research projects at Partner and
Lead institutions extends through all phases from experimental design to publication. This includes access to
state-of-the-art computational infrastructure supported by the NH-INBRE. To address the long-term goals for
broad workforce training in bioinformatics, we have developed a set of resources to support core bioinformatics
training in the context of a biology curriculum. In the next phase of our NH-INBRE BGC, we propose to expand
both the scope of bioinformatics research support and implementation of these curriculum modules both within
New Hampshire and nationally by leveraging the participation of the nationwide IDeA network. Finally, we
intend to further extend this curriculum support and integrate an important focus on rigor and transparency in
bioinformatics. To accomplish these goals, we have three specific aims:
Aim 1: Improve the biomedical research capacity of the State of New Hampshire at the eight primarily
undergraduate institutions and the two Lead universities of the NH-INBRE by: a) Supporting NH-INBRE
research projects and enhancing bioinformatics expertise across the network through training in diverse
bioinformatics applications; b) Providing sustainable, accessible, cost-effective, and well-managed
computational infrastructure for data analysis, storage, and dissemination.
Aim 2: Create a sustainable, scalable, and impactful mechanism for bioinformatics training by continuing to
support the integration of bioinformatics into the undergraduate science curriculum. . For this funding period,
we propose to extend this curricular support program to at least four additional INBRE Bioinformatics Cores in
each of the four IDeA geographical regions, with the long-term goal to extend across all 24 INBRE programs.
Aim 3: Establish workforce development training and infrastructure for advancement of Rigor and
Reproducibility in bioinformatics by a) Promoting transparency of bioinformatics analysis and b) Establishing
best practices for accurately presenting data and methods for INBRE-funded research.
Achieving these goals will support the development of key skills and rigorous practices in line with the
overarching goals as defined in the NIH strategic plan for data science. In particular, our training and support
enforces the FAIR principles where data and analysis should be Findable, Accessible, Interoperable and
Reusable.